High-throughput characterization and engineering of brighter luciferases

Project Summary
Bioluminescence Imaging (BLI) is a non-invasive method that enables the monitoring of
in vitro and in vivo biological events, cells, and molecules. In BLI, the bioluminescent
enzyme luciferase is used as a reporter. The detection limit, versatility, and temporal and
spatial resolution of BLI assays consistently exceeds fluorescence-based methods in the
context of deep tissue or whole animal imaging applications. Thus, BLI is a critical
imaging tool for whole animal imaging applied to both the study of diseases as well as in
the evaluation of potential therapies. The most frequently used enzyme for BLI is Firefly
luciferase (F-Luc), the luciferase enzyme from the North American firefly (Photinus
pyralis). Currently, F-Luc is highly effective for imaging single events or molecules;
however, engineering of F-Luc is needed to improve imaging applications where multiple
events are simultaneously monitored. In our prior R15 award, we developed novel
biochemical methods that can rapidly assess the effect of hundreds to thousands of
amino acid changes on F-Luc’s function and then applied those discoveries to create
improved F-Luc mutant enzymes. In this proposal, we apply our previously developed
methodology to ask a new biochemical question that will lead to improved engineered
enzymes. Specifically, while it is well known that the C-terminal domain (CTD) of F-Luc is
functionally important to the protein, it has been rarely applied for engineering improved
enzymes. We hypothesize that this is due to the flexibility of this region of the enzyme,
which makes it challenging to know which regions of the protein are best to mutate to
create improved variants. Here, we propose to systematically probe this region of the
protein to identify amino acid positions that are important for key parameters; we will then
directly apply this to create improved F-Luc probes. In Aim 1, we will discover amino acid
changes that inactivate the protein, improving our biochemical understanding of the
functional role of the C-terminal domain. In Aim 2, we will discover amino acid changes
that change the color of F-Luc emission and leverage our discoveries to create an
improved variant of a current leading multicomponent imaging probe. In Aim 3, we will
discover amino acid changes that improve the light output of another multicomponent
imaging probe, Pistachio. In addition to creating improved probes for multicomponent
imaging, this work will shed light on the function of this understudied domain and
demonstrate that the C-terminal domain can be used to engineer improved probes.

Public health relevance
Project Narrative Bioluminescent imaging (BLI) is an extremely powerful method for studying and tracking disease-causing cells and biological molecules in an organism. BLI relies on a protein, luciferase, to generate light when it comes into contact with its partnering molecule, luciferin. Here, we propose to develop and apply new methods for improving these proteins commonly used in BLI.